Apolipoprotein Proteoforms: Exploring Their Relationships with Cardiometabolic Health and Coronary Heart Disease Events

ABSTRACT
Cholesterol concentration in the blood is one of the primary determinants of coronary heart disease (CHD)
events. Human apolipoproteins (APO) serve as binding ligands as well as cofactors for enzymatic interactions
that mediate cholesterol metabolism. Apolipoproteins are also central to the pathobiology of atherosclerosis
through direct effects on lipid metabolism as well as atherosclerosis initiation, propagation, inflammation, and
plaque instability.
Human APOs are frequently post-translationally modified, which alters protein function and human phenotype.
For example, post-translational modifications (PTMs) such as glycosylation of apoB may increase the
synthesis and excretion of apoB lipoproteins and lead to adverse cholesterol profiles. Our prior work strongly
suggests that PTMs of human APOs may be a biologic pathway through which adiposity and insulin resistance
modify cholesterol concentrations and downstream CHD events. Further, preliminary data from our group
indicates that the relative abundance of APO PTMs in atherosclerotic plaque varies substantially from APO
PTMs found in plasma, suggesting that PTM of human APOs may partially mediate of atherosclerosis
propagation.
Our group has identified 18 PTM’s of apoA-I, 9 of apoA-II, 2 of apoA4, 32 glycosylated PTMs of apoB-100, 13
of apoC1, 14 of apoC2, and 23 of apoCIII, and 18 of apoE. However, we have not quantified the associations
of these APO PTMs with adiposity, insulin resistance, downstream atherogenic lipid concentrations and CHD
events. Nor have we comprehensively characterized APO PTMs found in atherosclerotic plaque and plasma.
Therefore, the overall objective of this study is to characterize the full spectrum of APO PTMs in human plasma
and to quantify their associations with upstream adiposity and insulin resistance and downstream atherogenic
lipid levels and CHD endpoints (fatal/non-fatal MI) in the population-based Multi-Ethnic Study of
Atherosclerosis Cohort. We will also explore differences in APO PTMs across paired samples of human carotid
and femoral atherosclerotic plaque and plasma. Characterization and cataloguing of apolipoprotein PTMs and
understanding their associations with prior exposures to adiposity and insulin resistance and subsequent lipid
levels and CHD endpoints will lead to novel insights into lipid metabolism and atherogenesis and may provide
novel targets for therapy.

Public health relevance
PROJECT NARRATIVE Apolipoproteins are a family of proteins that mediate cholesterol metabolism, and the coronary heart disease risks associated with serum cholesterol levels. Apolipoproteins are chemically modified in the body and these modifications affect the rate of degradation, the location, and the function of the proteins. In this study we will characterize the modifications present in excised arterial plaques specimens as well as 1,000 participants of the Multi-Ethnic Study of Atherosclerosis and Coronary Artery Risk Development in Young Adults studies and we will assess the associations between these different modifications and increased central adiposity, insulin resistance, and coronary heart disease events.